Circadian regulation of mitochondrial function by muscle RORs to promote healthy aging

PROJECT SUMMARY / ABSTRACT
A fundamental challenge in our rapidly aging society is how to extend healthspan, or maintain robust fitness
without major diseases. The circadian clock, our intrinsic timer, is a pivotal cellular mechanism to promote health
and healthy aging, as both loss- and gain-of-function studies have provided strong experimental evidence for a
causative role of circadian rhythms in aging. This is important because in humans, environmental circadian
disruptions associated with modern 24/7 lifestyles also aggravate disease risk and age-related decline. Despite
growing functional insights, a significant gap in knowledge remains regarding cellular mechanisms and
interventional strategies that impinge on circadian timing to promote healthy aging. The ROR (Retinoid acid
receptor-related Orphan Receptor) subfamily of nuclear receptors are key clock components, functioning to
sustain oscillatory robustness and phase which is known to alter with age. We previously identified an agonist of
RORs called Nobiletin (NOB) and demonstrated a strong efficacy of NOB to improve physiological fitness in
disease models and aged mice. Extending the pharmacological gain-of-function studies, we recently generated
muscle-specific double knockout of Rora and Rorc in mice (Ror mDKO), and found that adult and aged Ror
mDKO mice showed impaired skeletal muscle function and mitochondrial dysfunction in a circadian time-
dependent manner. Importantly, circadian transcriptomic analysis showed significantly altered circadian
expression (level, amplitude and phase) of OXPHOS genes. We hypothesize that RORs control mitochondrial
respiration and skeletal muscle function via circadian transcriptional and epigenetic mechanisms, and play a
modifiable role in lifestyle interventions to enhance healthy aging. In Aim 1, we will comprehensively investigate
the role of RORs in age- and circadian time-dependent changes in mitochondrial activity and homeostasis in
skeletal muscle. In Aim 2, we will determine circadian transcriptional and epigenetic mechanisms by RORs in
skeletal muscle, especially in the concerted regulation of OXPHOS gene expression. In Aim 3, combining timed
exercise and NOB treatment, we will determine the requisite role of RORs in circadian interventions to prolong
healthspan and lifespan. Together, the proposed studies will provide key mechanistic insights into circadian
regulation of skeletal muscle mitochondria, and pinpoint RORs as an actionable target for lifestyle interventions
to enhance healthy aging. The innovations include new insights into the function and mechanisms of RORs in
skeletal muscle aging, a novel tissue-specific double KO mouse line and circadian epigenetic/3D genome
studies, and versatile circadian interventions. We have assembled an excellent investigator team with
complementary expertise and demonstrated track records in aging, circadian rhythms, mitochondrial
metabolism, genetic/epigenetic regulation, and interventions. Given the prevalent lifestyle-related circadian
perturbations and associated disease risks in our society, the proposed study may have broad basic and
translational impact, eventually leading to improved quality of life in the elderly.

Public health relevance
PROJECT NARRATIVE Relevance to public health: Our modern 24/7 lifestyle is accompanied by prevalent perturbation of our daily rhythms in activity, eating and sleep, compromising health and fitness in the increasingly aging population. Focusing on our biological timer called circadian clock and particularly its core component RORs, the current project will interrogate circadian (epi)genetic regulatory mechanisms of RORs in age-related metabolic decline and explore timed exercise to promote skeletal muscle function and overall healthy aging. These studies promise to elucidate novel regulatory mechanisms and may ultimately lead to actionable strategies to improve the quality of life in the elderly.